Administrative Core

PROJECT SUMMARY/ABSTRACT: Administrative Core
The Vanderbilt-Ingram Cancer Center SPORE in Gastrointestinal (GI) Cancer Administrative Core will support
all GI SPORE cancer-related research projects and investigators by managing SPORE resources,
communication and outreach, and by fostering interactions among investigators, collaborators, other VICC
SPOREs, other GI SPOREs, the patient and advocate community, and the National Cancer Institute. This
management and support will be accomplished by administrative and scientific meetings of GI SPORE
investigators with oversight provided by the Internal and External Advisory Boards.

Public health relevance
PROJECT NARRATIVE: Administrative Core The Administrative Core will be responsible for the organizational, administrative, and scientific management (both basic and clinical research) of the Vanderbilt-Ingram Cancer Center SPORE in Gastrointestinal (GI) Cancer program, which focuses on translational research that will substantially improve the management of colorectal cancer. This management and support will be accomplished through a series of oversight committees and organized administrative and scientific meetings of GI SPORE investigators, institutional representatives, and external advisors.